ACTG 343--THREE MAINTENANCE REGIMENS FOR HIV INFECTED SUBJECTS

The purpose of this study is to compare the proportion of subjects who sustain suppression of plasma HIV RNA to undetectable levels among the three regimens during the maintenance phase.